Nuclear encoded Humanin Isoforms and Mitochondria in Age-related Macular Degeneration

Age-related macular degeneration (AMD) is a leading cause of blindness in the aging population due to the
continuous deterioration of macular RPE and retina in the advanced stages of the disease including geographic
atrophy (GA) and neovascular AMD (nAMD). In nAMD, the anti-VEGF therapy effectively reduces the incidence
of blindness in some patients, but fails in others. Identifying new molecular targets for developing treatment to
prevent the onset of nAMD is thus an urgent and unmet need. In this proposal, we will target this knowledge gap
focusing on MTRNR2L1, a novel nuclear encoded humanin isoform gene. In a recent RNA sequencing study,
we identified MTRNR2L1 as the top upregulated gene in the macular RPE and retina from human donor eyes
with intermediate AMD or nAMD. Moreover, our preliminary study demonstrated that MTRNR2L1 expression is
significantly upregulated in RPE cells by several factors related to AMD pathogenesis including oxidative stress,
hypoxia, and inflammation. Despite a high sequence similarity and a similar tissue expression pattern with
humanin, the biological function of MTRNR2L1 is currently unknown. Thus, in this application we seek to
elucidate the function of MTRNR2L1 in human RPE and choroidal cells and explore its potential implication in
nAMD pathogenesis. Specifically, we will address whether MTRNR2L1 is a protein-encoding gene or a lncRNA
using molecular biology approach and elucidate the role of MTRNR2L1 in mitochondrial regulation and cell
survival in RPE cells exposed to endoplasmic reticulum (ER) and oxidative stress in early AMD. Furthermore,
we will determine if MTRNR2L1 plays a role in the regulation of pro-angiogenic factor production from RPE cells
and in the regulation of angiogenic activities of choroidal endothelial cells. We anticipate that the proposed
studies will provide proof-of-concept evidence for a novel role of MTRNR2L1 as a molecular target in the AMD
progression and transition to nAMD. The findings will also lay a foundation for future studies on other nuclear
humanin isoform genes in AMD and beyond.

Public health relevance
PROJECT NARRATIVE Age-related macular degeneration (AMD) is the leading cause of central vision loss in the aging population and an effective treatment to prevent disease progression to the sight-threatening late stages is lacking. The goal of this application is to identify a novel molecular target in AMD development and in the transition from the early or intermediate stage to late neovascular AMD. The project will also address a longstanding fundamental question to understand the biological function of a nuclear gene that is recently implicated in many human diseases.